Mitochondrial Fidelity and Homeostasis

PROJECT SUMMARY/ABSTRACT
The overall vision of the proposed research program is to determine how evolutionary conserved
mitochondrial quality control modules function to maintain cell survival, and how these functions can be
manipulated to achieve clinical benefits. Research in the Khalimonchuk lab is focused on providing a better
understanding of multilayered processes that mediate mitochondrial biogenesis, function and integrity. The
general goals include: 1) thorough molecular characterization of factors involved; 2) dissection of their roles
and concerted action in relevant biological mechanisms; and 3) investigation of associated regulatory and
signaling events and their potential therapeutic relevance. To that end, this MIRA proposal focuses on a group
of fundamental mechanisms that mediate mitochondrial fidelity and preserve normal mitochondrial functions
throughout a lifecycle of a cell/organism. The mitochondria and its complex protein homeostasis (proteostasis)
network involve multiple dynamic processes and pathways that adapt to homeostatic challenges and change
over time. The multifaceted biological roles of these mechanisms are highly relevant to both normal cellular
physiology and a wide range of human disorders for which no effective therapies presently exist. Progressive
mitochondrial failure has emerged as a central causative factor of prevalent degenerative diseases such as
glaucoma, hearing loss, Parkinsonism, amyotrophic lateral sclerosis, various neuropathies, dementia,
cardiovascular disorders, and certain cancers. In spite of much research, the molecular etiology of these
pathologies remains obscure. Thus, a greater understanding of the mechanisms that mediate mitochondrial
fidelity, function, and integrity, and how failure of these mechanisms drives the above clinical manifestations, is
of central importance. Unified by an overarching topic of mitochondrial fidelity and protein homeostasis, this
research program seeks to study: 1) the mechanisms that proteolytically control/regulate protein stability,
abundance, assembly, and repair within the inner mitochondrial membrane and 2) how a delicate protein
homeostasis in the mitochondrial matrix is established and maintained. In each case, the proposed work will
focus on a group of dedicated versatile factors that mediate mitochondrial self-preservation and are highly
relevant to human health. The goal is to address unresolved questions concerning the functional roles of key
molecular factors using two lauded complementary models, the yeast Saccharomyces cerevisiae and cultured
human cells. The research will uncover novel mechanisms of regulation, dynamic integration, and concerted
spatiotemporal action that are critical for mitochondrial sub-proteomes to adjust to homeostatic insults and
physiological demands and challenges. Successful outcomes from this project will provide unprecedented
insights into the coordination of mitochondrial metabolism, bioenergetics, and proteostasis and challenge
current views on mechanisms of age-associated maladies. They may also aid in the development of new
treatment/prophylaxis strategies against degenerative diseases and related pathologies that occur with age.

Public health relevance
PROJECT NARRATIVE This project addresses a diverse group of fundamental molecular mechanisms that mediate mitochondrial fidelity and are central to human health. Progressive mitochondrial failure due to defects in the organelle’s quality control is increasingly being recognized as a cause of highly prevalent degenerative diseases, but the mechanisms of pathology remain obscure. Understanding how versatile quality control mechanisms contribute to mitochondrial and cellular protection will provide the foundational knowledge needed to develop cost- effective treatment or prophylaxis strategies against degenerative diseases and related pathologies that occur with age.